Impact of Overload and Overuse Following Subscapularis Tears: Mechanisms of Shoulder Joint Damage

Rotator cuff tears affect millions of individuals each year in the United States, impacting
veterans and civilians alike. Tears dramatically alter joint mechanics leading to significant
damage to articular cartilage and adjacent (intact) tendons within the shoulder. This damage
leads to loss of function, pain, tear progression, and even tendon re-tear following repair.
Therefore, identifying mechanisms of joint damage after tendon tear is an active area of
research. We have previously discovered how joint damage occurs following supraspinatus and
infraspinatus tears using an in vivo rat rotator cuff tear model. These results altered clinical
practice by clearly demonstrating that loss of the anterior-posterior force couple leads to
permanent detrimental changes to the shoulder joint. While subscapularis tendon tears were
once thought to be uncommon, increased use of arthroscopy and improved imaging have led to
a dramatic increase in subscapularis tear diagnosis, specifically in ~ 50% of patients undergoing
rotator cuff repair. Furthermore, it has been suggested that unrecognized subscapularis tears
may be a source of chronic dysfunction and pain. However, no studies have examined the
critical question of how subscapularis tendon tears affect the shoulder joint, and as a result, a
clear best clinical approach has not been identified for this common and debilitating condition.
Therefore, the clinical objective of this work is to specifically determine the extent and
mechanisms of shoulder joint damage, functional alteration, and pain that result from rotator cuff
tears involving the subscapularis. We hypothesize that loss of the anterior-posterior force couple
after subscapularis tear leads to detrimental joint damage, loss of function, and pain, and that,
due to the critical role of the subscapularis, these effects are significantly increased when
compared to a supraspinatus tear alone. Additionally, we hypothesize that these detrimental
changes are exacerbated by joint overuse after tendon detachment.
Our well-characterized, controlled in vivo pre-clinical model system is ideal for the posed
questions. The hypotheses will be evaluated with a series of tendon detachments followed by
comprehensive combination of mechanical property measurements, tissue composition
measures, and longitudinal in vivo functional evaluation of joint kinematics, shoulder range of
motion, and grip strength of the affected limb, defining how in vivo changes are reflected in ex
vivo measurements. Experiments will be repeated with the addition of a treadmill overuse
protocol post-injury to identify the compounding effects of overuse after a tendon tear. The
proposed research will identify how subscapularis tears affect joint health and function, the
consequences of an undiagnosed tear, and the role of shoulder overuse after subscapularis tear
in intensifying these issues, while also providing important insights into chronic shoulder pain
and loss of function. Results from these studies will be used to appropriately design targeted
randomized controlled trials. Subsequently, results from one or more prospective clinical trials
will have a clear and direct impact on clinical care. Results from this pre-clinical study will
provide critical information that will ultimately guide treatment strategies for subscapularis tears
in order to reduce pain, improve function, and preserve long-term shoulder joint health.

Public health relevance
Previously believed to be uncommon, subscapularis tendon tears are present in 50% of patients undergoing rotator cuff repair. Unrecognized subscapularis tears may be a source of chronic shoulder pain and dysfunction. The objective of this study is to determine the effects of subscapularis tendon tears on shoulder joint damage, function, and pain. The study will identify the mechanisms of these changes and delineate the contribution of the tear alone versus the potential compounding effect of a tear in the setting of shoulder overuse. Results will highlight the importance of detection and influence future clinical studies to reduce pain, improve function, and preserve shoulder joint health. With the high prevalence of subscapularis tears now recognized, this study will have significant impact on the aging and veteran populations, and is highly relevant to the Veterans Health Administration’s mission.